BIOCHEMISTRY AND FLOW CYTOMETRY ANALYSIS OF STORED RED CELLS

Red cell ghosts will be tested for Sodium/Potassium ATPase activity as a measurement of membrane pump function. Decrease in this activity during red cell storage will be correlated with measurements of red cell associated autologous IgG. These studies will serve as the foundation for studies on improved methods of red cell storage.